NMR Studies of Retroviral Nucleic Acid Binding Proteins

7. Project Summary/Abstract
The overall goal of this project is to understand how the HIV-1 5′-leader RNA differentially directs diverse
functions during viral replication, including intracellular trafficking, initiation of translation, recruitment of viral
structural proteins (called Gag), and nucleation of virus assembly. Proposed studies build on our recent
discovery that HIV-1 RNAs are transcribed with one, two or three 5ʹ-guanosines via alternate (heterogeneous)
transcriptional start site usage – a new paradigm in HIV-1 RNA biology. Our studies revealed that 5′-capped
transcripts that begin with a single guanosine (Cap1G) adopt a structure that sequesters the 5′-cap, promotes
dimerization, and exposes Gag binding sites, thereby promoting their functions as genomes (gRNA). In
contrast, 5′-capped transcripts that begin with two or three guanosines (Cap2G/Cap3G) adopt monomeric
structures with an exposed 5′-cap that function in splicing and translation (mRNAs). The central hypothesis
guiding our proposed studies is that cap sequestration enables the HIV-1 gRNA to avoid capture by the cellular
RNA processing and translation machinery, and that a small number of Gag proteins (~2 dozen) are
cooperatively recruited to assembly sites on a well-defined packaging signal (ΨCES) located within the gRNA 5′-
leader. We now aim to identify molecular determinants of alternate transcription initiation and exploit this
knowledge to differentially examine HIV-1 mRNA and gRNA trafficking and interactions in cells, probe RNA
structural changes that occur during virus assembly and maturation, and identify key interactions that promote
Gag:RNA assembly and might be exploited for drug targeting. Preliminary NMR and EM findings suggest that it
should now be possible to determine the 3D structure of the Gag:RNA complex that nucleates HIV-1 virus
particle assembly.
NMR studies of large RNAs and protein-RNA complexes are technically challenging – the average size of
NMR-derived RNA structures in the RNA Structure Database is only 30 nucleotides. But the potential payoff of
the proposed studies is substantial and could ultimately lead not only to a more detailed understanding of how
HIV-1 replicates, but also to the development of new approaches for the treatment of AIDS and to the
engineering of gene delivery vectors with improved packaging efficiencies.

Public health relevance
8. Project Narrative The untranslated 5’-leader of the human immunodeficiency virus (HIV) genome directs multiple functions during viral replication, including the selective packaging of two copies of the unspliced genome during virus assembly and the recruitment of cellular factors to HIV-1 mRNAs to promote processing and translation. Understanding the molecular structures and mechanisms responsible for these essential functions will lead not only to a more detailed understanding of how HIV replicates, but also to the development of new approaches for the treatment of AIDS and the engineering of improved gene delivery vectors with greater packaging efficiencies.